Decoding the role of chromatin architecture in alveolar epithelial cell identity and disease

Project Abstract
The alveolar epithelium is composed of two distinct cell types—alveolar epithelial type I (AT1) cells, which
facilitate gas exchange, and alveolar epithelial type II (AT2) cells, which act as progenitors for AT1 cells.
Successful lung repair following alveolar injuries requires AT2 cell proliferation and differentiation into AT1 cells,
a process that involves the restructuring of gene regulatory networks and cell-type specific chromatin landscapes
that underly these two cell fates. A dysfunctional regenerative response has been observed in a variety of severe
lung diseases, involving AT2 cells acquiring a pathologic, alveolar-basal intermediate (ABI) cell state at the
expense of an AT1 fate. The mechanisms that facilitate the cell fate decisions involved in AT2 cell maintenance
and differentiation are not well understood, which has resulted in a lack of effective treatments to promote
alveolar regeneration. This project aims to identify and characterize regulatory, 3-dimensional “hubs” of
chromatin interaction that instruct distinct alveolar epithelial cell fates, and to determine how these hubs and their
associated transcription factors regulate the acquisition of healthy and disease-associated states. Using human
induced pluripotent stem cell (iPSC) models of AT1- and AT2-like cells (iAT1s and iAT2s), we will apply advanced
chromatin mapping techniques to identify cell-type specific enhancer-promoter interactions and to characterize
chromatin hubs that potentially regulate normal AT1 and AT2 cell identity. In Aim 1, we will map these interactions
in healthy iAT1 and iAT2 cells, comparing their chromatin landscapes to pinpoint regulatory hubs that we
hypothesize are responsible for cell-type specific gene expression. In Aim 2, we will explore the effects of
haploinsufficiency of the lung lineage transcription factor, NKX2-1, on chromatin topology of iAT2 cells,
hypothesizing that reduced NKX2-1 expression disrupts normal AT2 cell identity and favors a pathological ABI
state. The findings from this research will enhance our understanding of the chromatin-based mechanisms that
control lung cell fate decisions and provide insights into how disruptions of chromatin organization contribute to
pulmonary disease.

Public health relevance
Project Narrative 3D chromatin architecture is known to play an important role in gene expression and cell identity and disruption of normal chromatin architecture has been implicated in a variety of disease. The goal of this project is to define the chromatin landscape that controls pulmonary alveolar epithelial cell fates and to investigate how haploinsufficiency of the lung lineage transcription factor, NKX2-1, may perturb chromatin topology and lead to a pathologic alveolar-basal intermediate (ABI) cell state associated with lung disease. Understanding these mechanisms could provide new insights into the epigenetic regulation of alveolar regeneration and inform therapeutic approaches for diseases such as pulmonary fibrosis and childhood interstitial lung disease.